Emory Vaccine and Treatment Evaluation Unit - KidCOVE

Narrative The Emory VTEU will participate and enroll children into “A Phase 2/3, Two-Part, Open-Label, Dose-Escalation, Age De-escalation and Randomized, Observer-Blind, Placebo-Controlled Expansion Study to Evaluate the Safety, Tolerability, Reactogenicity, and Effectiveness of mRNA-1273 SARS-CoV-2 Vaccine in Healthy Children 6 Months to Less Than 12 Years of Age (KidCOVE)”. 1

Public health relevance
Summary/Abstract The Emory VTEU has proven essential in the fight against the COVID-19 pandemic. This supplement will fund evaluation of mRNA-1273 in a pediatric clinical trial (KidCOVE). 1